Stanford Cardiovascular Summer Research Training Program for Medical Students

PROJECT SUMMARY
The objective of the Stanford Cardiovascular Summer Research Training Program for Medical Students is to
provide meaningful ten-week summer research experiences to a diverse cohort of 15 first-year medical students
from across the country in the field of cardiovascular science. Our long-term goal is to bolster the pool of
physician-scientists in our workforce by 1) increasing their diversity, 2) exposing them to the landscape of 21st
century translational medicine, and 3) providing them with a strong foundation in rigor, reproducibility and the
responsible conduct of research. We will work toward the first goal by partnering directly with Meharry Medical
College (co-PI Dr. Stephanie McClure) and the University of Puerto Rico (co-PI Dr. América Facundo) to
provide a dedicated track for underrepresented minority (URM) medical students from their institutions to obtain
research experiences with Stanford faculty. 40-60% of our placements will be dedicated to medical students
from underrepresented backgrounds. After recruiting a diverse pool of medical students, we will provide our
trainees with a comprehensive ten-week curriculum that will prepare them for careers as physician-scientists in
cardiovascular medicine. 80% of trainee time will be devoted to a cardiovascular research project in the lab of a
Stanford physician-scientist faculty mentor. The remaining 20% of their time will be spent in a comprehensive
curriculum comprised of seminars in cardiovascular science, research training, physician-scientist career
development opportunities and social events. To accomplish the second goal of preparing trainees for innovative
research in translational medicine, students will be exposed to scientific opportunities that are especially enriched
at Stanford. Precision medicine, industry collaborations, and familiarity with clinical trials are all important
components of the research endeavors for future physician-scientists. To accomplish our third goal of providing
trainees with a strong foundation in rigor, reproducibility and the responsible conduct of research, we will provide
a dedicated curriculum to address these topics under the guidance of leaders in the fields of research ethics and
the philosophy of science. The program’s success and longevity will be monitored and improved upon through
a robust plan for internal and external evaluation. The Program Directors and faculty mentors for this T35 have
ongoing state-of-the-art cardiovascular research programs spanning basic, translational, clinical, and population
level domains. Together they have the mentoring expertise and the available resources to support this T35
summer research program, which will train a diverse cohort of medical students to become responsible,
collaborative, and innovative physician-scientists.

Public health relevance
PROJECT NARRATIVE With the rise in the impact of cardiovascular disease on US and world health, it is critical to train the next generation of physician-scientists in translational cardiovascular research. Participation in mentored research provides valuable training and increases the likelihood that medical students will continue to pursue research as part of their careers. This multidisciplinary Stanford Cardiovascular Summer Research Training Program for Medical Students is designed to train a diverse cohort of medical students in basic, clinical, translational and population level cardiovascular science, to provide them with a strong foundation of medical ethics, and to foster their development into investigators dedicated to identifying innovative solutions and capable of translating research into clinical success to combat cardiovascular disease.